IL-9-dependent interstitial macrophage function in the allergic lung

PROJECT SUMMARY / ABSTRACT: IL-9-dependent interstitial macrophage function in the allergic lung
Despite IL-9 functioning as a pleiotropic cytokine in mucosal environments, the IL-9 responsive cell repertoire is
still not well defined. In a thorough study to identify IL-9-responsive cells, we found that IL-9 mediates pro-allergic
activities by targeting lung macrophages. IL-9 inhibits alveolar macrophage expansion and promotes recruitment
of monocytes that develop into CD11c+/- interstitial macrophage populations. Interstitial macrophages are
required for IL-9-dependent allergic responses. Mechanistically, IL-9 affects the function of lung macrophages
by inducing Arg1 activity. Adoptive transfer of Arg1+ lung macrophages but not Arg1- lung macrophages can
recover allergic inflammation that is lost in Il9r-/- mice. In parallel, the elevated expression of IL-9, IL-9R, and
Arg1 is correlated with disease in asthma patients. Thus, our studies uncover an IL-9/macrophage/Arg1 axis as
a potential therapeutic target for allergic airway inflammation. In this renewal application we will leverage single
cell RNA-seq datasets to further define the interstitial macrophage population that displays pro-allergic function.
We will determine the IL-9-dependent pathways that lead to changes in macrophage gene expression. Finally,
we will determine how Arg1-dependent metabolic pathways impact intrinsic gene expression in macrophages.
Together, these studies will establish a detailed understanding of macrophage function in the allergic lung and
identify pathways that can be explored for therapeutic value.

Public health relevance
PROJECT NARRATIVE The development of allergic inflammation in the airways depends upon cytokines that are secreted by various cells types in the lung to orchestrate the inflammatory process. This is dependent upon cells that respond to those cytokines and we have identified macrophages as critical responding cells to the cytokine IL-9. In this proposal we define macrophage populations that are most responsive and will elucidate some of the mechanisms of IL-9 function within this population.